Training the Next Generation of Surgeon-Scientists in Pancreatology

Project Summary
The University of Minnesota Training the Next Generation of Surgeon-Scientists in Pancreatology Program will
provide independent translational science training experience in pancreatology through a team mentoring-based
program for the development of translational science projects as well as University of Minnesota Graduate
School curriculum and thesis. The program uniquely focuses on developing professional surgeon-scientists with
skills to work collaboratively with PhD and other investigators. A team comprised of an individual surgeon-
scientist and a PhD or other appropriate investigator will mentor each resident; both will provide mentorship with
the goal of developing surgeon-scientists trained in collaborative, transdisciplinary, translational research. As
part of this effort, we will expect all trainees to complete a Masters in Surgical Science. We believe that the
combination of these skills and experience within a team science setting will permit the acquisition of skills to
effectively function as a surgeon-scientist in the future. Our program areas of strength include nationally and
internationally recognized basic and translational research in the areas of acute and chronic pancreatitis,
pancreatic cancer, and pancreatic islet transplantation with active involvement in clinical practice. The Executive
Committee will provide administrative guidance to the Co-Directors in the selection of trainees and Trainee
Mentoring Team; development of the individual trainee program, including an Individual Development Plan;
evaluation of trainee and program progress, and strategic planning for future direction. The External Review
Committee provides independent, extramural review of the program content and process. In summary, a 2-year
dedicated research period, as part of a research training program during the surgery residency is highly likely to
increase the number of surgeon-scientists poised to make lasting contributions through collaborative team-based
research.

Public health relevance
Project Narrative The renewal of the Ruth Kirschstein National Research Service Award (NRSA) Institutional Research Training Grant (T32) ‘Training the Next Generation of Surgeon-Scientists in Pancreatology,’ will enable training of future surgeon-scientists in collaborative, transdisciplinary, translational research in diseases of the pancreas. The program will train surgical residents and fellows, providing each with the core competencies needed to develop into independent, productive researchers poised to make lasting contributions through collaborative, team-based research.